CHANGES IN MAGNETIC RELAXATION TIMES AFTER MYOCARDIAL INFARCTION

The purpose of this study was 1) to examine the serial changes in relaxation times after coronary occlusion and to measure these values from in-vitro tissue samples and 2) to determine how these changes relate to reduction in myocardial blood flow, changes in water content, and histopathology.